Enrichment Program

Enrichment Program: Summary
The mission of the UCSF-NORC Enrichment Program remains to provide exceptionally high-quality
opportunities for investigators at UCSF to exchange research information, for recognized experts in obesity
and nutrition to enlighten the UCSF community on both research and clinical practice, and for faculty to
educate trainees, as well as to strengthen the multidisciplinary and collaborative network that links nutrition and
obesity research being conducted across UCSF. However, the Program has also grown in specific and
transformative ways. This growth includes A) Networking with other academic institutional NORCs from around
the country to increase scientific exchange between colleagues; B) Specific efforts to engage, cultivate, and
grow a diverse clinical and translational research community relevant to NORC objectives; and C) Establishing
the UCSF-NORC as a hub for sharing research in obesity and nutrition with institutions across Northern
California. The elements of the Enrichment Program (detailed below), in particular those developed since initial
grant funding, are impressive given they were fully implemented in only four years.
The Director of the Enrichment Program, Dr. Suneil Koliwad (also Co-Director of the NORC) has been tasked
with implementing the Program's mission over the funding period. Dr. Koliwad performs this function in close
collaboration with the Center Director (Vaisse, PI) and an oversight committee that includes the other NORC
Core and Program Directors, the principal investigators of relevant NIDDK-sponsored T32 training grants and
the organizers of key NORC-connected seminar series and symposia.
The specific objectives of the program are to:
1. Strategically integrate a complementary yearlong set of speakers regularly interspersed in the weekly
UCSF Endocrine Grand Rounds, Diabetes and Obesity Seminar Series, and institution-wide talks within the
graduate school seminar series. This effort includes the recruitment of both preeminent scientists working at
UCSF, speakers from neighboring top-tier academic centers within the region, and renowned NORC visiting
professors (in collaboration with the Diabetes Center Distinguished Speakers Series) from around the world.
2. Oversee the maintenance of a high-quality weekly Obesity and Nutrition Journal Club at UCSF in order to
implement further the training components of the NORC mission.
3. Conduct and strategically continue to grow the annual UCSF Diabetes, Obesity, and Nutrition Retreat.
4. Continue to host interdisciplinary collaborative enrichment activities, including a clinical engagement
symposium co-sponsored by the Center for Obesity Assessment and Treatment (COAST), which incentivize
core utilization by promoting joint projects between clinical and basic researchers at UCSF.
5. Co-host the annual COAST Sugar, Stress, Environment, and Weight (SSEW) symposium.
6. Provide speakers as part of continuing medical education (CME) activities relevant to obesity and nutrition.
By facilitating continued achievement of these specific objectives, renewed funding of the UCSF-NORC
Enrichment Program will allow it to realize the ongoing mission and long-term goal of fostering a highly
collaborative, world-class learning environment that advances and promotes successful basic, translational,
and clinical nutrition and obesity research at UCSF and across the Northern California Region.